LONG-TERM OXYGEN TREATMENT TRIAL (LOTT) PHARMACOGENOMICS ANCILLARY STUDY

DESCRIPTION (provided by applicant): Chronic obstructive pulmonary disease (COPD) is the fourth leading cause of death in the United States and mortality from COPD continues to increase. Long-term oxygen therapy has been shown to reduce mortality in COPD patients with severe hypoxemia and is one of the only treatments for COPD with a proven survival benefit. The Long-term Oxygen Treatment Trial (LOTT) is an NHLBI-sponsored clinical trial to determine whether COPD patients with moderate hypoxemia will benefit from continuous oxygen therapy. Results of earlier studies in moderately hypoxemic COPD patients suggest heterogeneity in the response to oxygen. In other diseases, pharmacogenetic influences on oxygen toxicity and on oxygen benefit have been demonstrated. However, the impact of pharmacogenetics on the response to oxygen therapy in COPD is unknown. The overall hypothesis is that a set of oxygen-responsive genes will be differentially expressed in COPD patients treated with supplemental oxygen and that inter-individual variation in these oxygen-responsive genes will predict change in exercise tolerance and disease-specific quality of life (QoL) in COPD patients treated with long-term oxygen therapy. To test this hypothesis, we will address three Specific Aims: 1) Genomic profiling of response to oxygen therapy: We will collect peripheral blood for RNA at baseline (pre- randomization) and at follow-up, and perform whole-genome gene expression profiling in 100 LOTT participants randomized to supplemental oxygen to define a set of genes that are significantly up- or down- regulated in response to oxygen therapy. We will test whether gene expression profiles predict change in exercise capacity and disease-specific QoL in response to long-term oxygen therapy. 2) Pharmacogenetics of long-term oxygen therapy: We will genotype linkage-disequilibrium tagging single nucleotide polymorphisms (SNPs) in 40-50 differentially expressed oxygen-responsive genes in 800 subjects randomized to supplemental oxygen and test for association with change in exercise capacity and disease-specific QoL in COPD patients treated with long-term oxygen therapy. We will also test whether these SNPs are associated with gene expression of the differentially expressed oxygen-responsive genes. 3) Replication of pharmacogenetic associations: For 120 SNPs significantly associated with change in exercise capacity disease-specific QoL in the initial 800 subjects, we will genotype a separate set of 1200 LOTT subjects to replicate genetic associations for response to long-term oxygen therapy. Significance: This study will further our understanding of the effects of supplemental oxygen in COPD and may allow for better prediction of patients most likely to benefit or most likely to be harmed by long-term oxygen therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: The Long-term Oxygen Treatment Trial (LOTT) Pharmacogenomics Ancillary Study will improve our understanding of the effects of treating chronic obstructive pulmonary disease (COPD) patients with supplemental oxygen. The information gained may eventually allow physicians to predict which COPD patients are most likely to benefit or most likely to be harmed by long-term oxygen therapy. PROJECT NARRATIVE The Long-term Oxygen Treatment Trial (LOTT) Pharmacogenomics Ancillary Study will improve our understanding of the effects of treating chronic obstructive pulmonary disease (COPD) patients with supplemental oxygen. The information gained may eventually allow physicians to predict which COPD patients are most likely to benefit or most likely to be harmed by long-term oxygen therapy. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Chronic obstructive pulmonary disease (COPD) is the fourth leading cause of death in the U.S., and mortality from COPD continues to rise.1 In the early 1980s, the Nocturnal Oxygen Treatment Trial and the Medical Research Council study both found long-term oxygen therapy to reduce mortality in COPD patients with severe hypoxemia.2,3 Long term oxygen therapy is one of the only treatments for COPD with a proven survival benefit. The Long-term Oxygen Treatment Trial (LOTT) is an NHLBI-sponsored clinical trial to determine whether the survival benefit from continuous oxygen therapy will extend to COPD patients with moderate hypoxemia, which was not demonstrated in two studies performed in the 1990s.4,5 However, the results in moderately hypoxemic patients suggest heterogeneity in the response to oxygen, based on clinical characteristics. Several factors may contribute to the heterogeneity in response to long-term oxygen therapy in COPD patients. There could be differential responses to oxygen therapy, related to either benefit or toxicity, among individuals based on pharmacogenetic determinants of oxygen metabolism. Pharmacogenetic studies have not been widely applied in COPD. In other diseases, genetic influences on oxygen toxicity, and recently on oxygen benefit, have been demonstrated in both human and animal studies.6-10 However, the impact of pharmacogenetics on response to oxygen therapy in COPD is unknown. Genetic variants in oxidant-antioxidant pathway genes could be involved, but the results of previous studies of biologically plausible genes in COPD point out the limitations of candidate gene-based approaches.11 The most widely replicated COPD susceptibility genes have been those identified starting with a genome-wide search, traditionally based on genome-wide linkage analysis.12,13 An unbiased genome-wide approach can identify both suspected and novel genes for oxygen responsiveness in COPD. Therefore, we propose to identify genome-wide gene expression signatures of oxygen responsiveness in a sub-study of 100 patients from LOTT, nested within the full cohort of 3108 patients. Genetic associations with variants in differentially expressed genes will be tested initially in a sample of 800 patients, with significant associations validated in an additional 1200 patients from the cohort. We hypothesize that a set of oxygen-responsive genes will be differentially expressed in COPD patients treated with supplemental oxygen and that inter-individual variation in these oxygen- responsive genes will predict change in exercise tolerance and disease-specific quality of life (QoL) in COPD patients treated with long-term oxygen therapy. To test this hypothesis, we will address the following Specific Aims: 1. Genomic profiling of response to oxygen therapy: We will collect peripheral blood for RNA at baseline (pre-randomization) and at 12-month follow-up and perform whole-genome gene expression profiling in 100 LOTT participants randomized to supplemental oxygen to define a set of genes that are significantly up- or down-regulated in response to oxygen therapy. We will test whether gene expression profiles predict change in exercise capacity and disease-specific quality of life (QoL) in response to long-term oxygen therapy. 2. Pharmacogenetics of long-term oxygen therapy: We will genotype linkage-disequilibrium (LD) tagging single nucleotide polymorphisms (SNPs) in 40-50 differentially expressed oxygen-responsive genes from Specific Aim 1 in 800 subjects randomized to supplemental oxygen and test for association with change in exercise capacity and disease-specific QoL in COPD patients treated with long-term oxygen therapy. We will also test whether these SNPs are associated with gene expression of the differentially expressed oxygen- responsive genes from Aim 1. 3. Replication of pharmacogenetic associations: For approximately 120 SNPs significantly associated with change in exercise capacity or disease-specific QoL in the initial 800 subjects, we will genotype a separate set of 1200 LOTT subjects to replicate genetic associations for response to long-term oxygen therapy. The LOTT study represents a unique opportunity to define pharmacogenetic determinants of response to long-term oxygen therapy in moderately-hypoxemic COPD patients. Approximately one million patients annually in the U.S. receive long-term oxygen therapy through Medicare, at a cost of over $2 billion/year.14 The identification of genetic signatures of patients most likely to benefit, or at the greatest potential for harm, could have broad public health implications. By adding genetic factors to clinical predictors of oxygen- responsiveness, the LOTT Pharmacogenomics Ancillary Study may expand the practice of personalized medicine to patients suffering from COPD.